Quantitative Phase Imaging Meta-Sensors for Noninvasive Real-Time Capillaroscopy

ABSTRACT
Quantitative phase imaging is a powerful modality of widefield microscopy that allows visualizing transparent
biological cells and extracting important biophysical parameters with subcellular resolution. A potential
application of immediate and widespread impact is real-time imaging of blood cell flow in vivo by noninvasive
label-free capillaroscopy (particularly on the oral mucosa, due to the presence of capillaries in close proximity to
the surface and limited pigmentation). This capability could dramatically improve patient care management in
situations where venipuncture is impractical, such as with immunocompromised patients or in resource-limited
settings. Furthermore, it could significantly speed up decisions about life-saving treatments and provide dynamic
information for disease diagnosis that is not directly available from static parameters such as blood count.
However, existing techniques for in vivo capillaroscopy (by phase imaging or other methods) suffer from limited
image contrast, high system complexity, high cost, and/or slow speed that hinder their clinical adoption.
This project will demonstrate a new method for quantitative phase imaging that can be applied to noninvasive
real-time capillaroscopy with a particularly simple measurement setup – an epi-mode miniaturized microscope
with standard on-axis illumination and detection. The key innovation is the use of a new type of image sensors,
where an integrated photonic metasurface is used to produce a sharp dependence of responsivity on direction
of propagation of the incident light. These Phase Imaging Meta-Sensors (PIMSs) can simultaneously resolve
phase and amplitude contrast in a single shot, with direct background subtraction and quantitative phase
reconstruction capabilities. By virtue of their unique characteristics, these devices can provide an unmatched
combination of image quality, system miniaturization, measurement simplicity, spatial resolution, speed, and low
manufacturing cost that makes them ideally suited for capillaroscopy and other in vivo microscopy applications.
The project goal will be achieved through three specific aims: (1) the development of dielectric metasurfaces
enabling PIMS operation with uniform angular response across the bandwidth of green LEDs; (2) the fabrication
of these metasurfaces on the individual pixels of commercial CMOS image sensor arrays; and (3) the
development of a miniaturized PIMS microscope and its application to single-shot quantitative phase imaging
with thick scattering samples, ranging from controlled scattering phantoms to blood vessels in the developing
chick embryo. The latter samples will be used to demonstrate white blood cell counting with clinically relevant
accuracy – a key milestone for widespread adoption in noninvasive real-time capillaroscopy. The image sensing
technology developed through these aims can be expected to significantly expand the reach and functionality of
life-saving blood testing, and more generally open up new applications in multiple areas of in vivo microscopy,
such as microendoscopy for cancer surgical guidance.

Public health relevance
NARRATIVE The ability to visualize blood cell flow in vivo by noninvasive label-free capillaroscopy could extend the reach of blood testing to situations where venipuncture is impractical (e.g., with vulnerable patient populations or in resource-limited settings), speed up decisions about life-saving treatments, and provide useful dynamic information for disease diagnosis. However, existing techniques suffer from limited image contrast, high system complexity, high cost, and/or slow speed that preclude a direct translational path to the bedside. We propose to demonstrate a new method for quantitative phase imaging (based on the use of specially designed angle- sensitive image sensors) that will enable high-contrast real-time capillaroscopy with a simple highly miniaturized epi-mode microscope.